Therapeutic Mechanism of CD47 Blockade in Suppressing Melanoma Metastasis

PROJECT SUMMARY
The overall goal of this project is to identify molecular regulators enabling immune suppressive properties of
metastatic melanoma and define cell lineages that mediate therapeutic function of CD47 blocking antibodies.
Our central hypothesis is that metastasizing melanoma cells avoid immune recognition by hyperactivating
CD47 promoter through NRF1 transcription factor. Overexpression of CD47 then modulates tumor immune
microenvironment in a way that inhibits melanoma destruction and antigen presentation by professional
phagocytes while at the same time stimulating myeloid derived suppressive cells (MDSCs) that negatively affect
T-Cell responses. When the proposed research studies are completed we will accomplish identification and
characterization of potent molecular and cellular targets that regulate CD47 dependent escape of immune
surveillance by metastasizing melanoma cells. Delineating these factors will also serve a clinically predictive
value to allow patient selection based on their immune cell repertoire resulting in the prolonged curative
responses and increased survival. Clinical significance of the proposed studies is also highlighted by the fact
that we will be using immune- humanized PDX models to characterize our findings in the setting most
physiologically relevant to the patient disease.

Public health relevance
PROJECT NARRATIVE We propose that the pathogenesis and disease advancement of melanoma requires signaling networks that evade detection of immune cells. Specifically, our studies will address the driving factors such as CD47 behind the promotion of melanoma tumor cells from primary to metastatic stage.